Professional to Plain Language Neural Translation: A Path Toward Actionable Health Information

Health literacy is key to making well-informed health decisions that improve outcomes. However, while the peer-
reviewed clinical literature contains valuable information to guide health decisions, it is generally written for an
audience of healthcare professionals. Even in the context of good general literacy, medical jargon and the
complex structure of professional language make this information especially hard to interpret. While efforts
have been made to summarize some of this literature in plain language to make it accessible to the general
public, these efforts depend on human expertise. This approach cannot scale to match the rapid pace at which
new findings emerge in the literature. Thus, there is an urgent unmet need for automated methods to enhance
the accessibility of the canonical biomedical literature to the general public. This problem can be framed as a
type of translation problem, between the language of healthcare professionals, and that of healthcare
consumers. The proposed research builds on recent advances in deep learning stemming from neural sequence-
to-sequence models, which were originally evaluated in machine translation tasks. In our recent work, we
showed these models can be effectively adapted to the task of translating between abstracts in the Cochrane
Database of Systematic Reviews (CDSR) and corresponding professionally-authored plain language
summaries. The resulting automatically-generated summaries outperformed those from other models in their
alignment with professionally-authored summaries. Furthermore, in a pilot user evaluation in which participants
were blinded as to summary provenance, they were generally judged favorably to their expert-authored
counterparts. In the proposed research we will develop this line of research further, by evaluating the utility of
additional pre-training and auxiliary fine-tuning tasks as a means to improve the quality of generated summaries.
We will also customize the models concerned to enhance their factual accuracy and readability using novel
auxiliary training objectives and post-processing procedures. We will evaluate our methods as compared with
robust baseline models in system-centric evaluations of content alignment with reference summaries, readability
and factual correctness. Using Mechanical Turk, we will conduct user-centric evaluations of the ease with which
summaries from best-performing models can be understood, as compared with CDSR expert-authored plain
language summaries. These evaluations will consider both perceived interpretability, and actual comprehension,
with the latter evaluated using sets of multiple choice questions to probe comprehension, recall and learning. In
doing so, the proposed research will advance the state-of-the-art in automated simplification and summarization
of the biomedical literature for consumption by the general public.

Public health relevance
Health literacy is a key factor in making informed healthcare decisions, but professional language is often difficult for the general public to understand. In this project we will train deep learning models to translate between professional and plain language health information, and develop methods to improve upon the accuracy and readability of the resulting plain language summaries. We will evaluate how easy it is for readers to understand automatically-generated summaries, as compared with expert-authored ones.